RNA-programmable cell-type targeting, editing, and therapy

Josh Huang Sept 6, 2020
RNA-programmable cell-type targeting, editing, and therapy
Abstract
Systematic identification and manipulation of cell types is necessary for dissecting mechanisms of biological
functions in health and disease. Although large-scale, single-cell transcriptome profiling now enables
identification of all major transcription-defined cell types in many organisms, easy and systematic experimental
access to all major cell populations is needed to physiologically and anatomically validate these statistical
“transcriptional clusters” as cell types and, more importantly, to interrogate their roles in tissue organization and
function. The difficulty of selectively manipulating cell types remains a critical barrier to such studies. Current
approaches to this problem mostly rely on germline DNA engineering, which is slow and expensive and poses
ethical issues, especially in humans and other primates. Cell-type transcriptional enhancers afford a non-
germline approach, but their identification and validation remain effort-intensive and costly. To overcome these
barriers, all of biomedical research urgently needs a novel approach to manipulate cell types in a way that is
specific, easy yet comprehensive, affordable, and generalizes across organs and species, akin to CRISPR-
based manipulation of genes. Here I propose to develop a paradigm-shifting technology that will enable RNA-
programmable cell-type targeting and manipulation based on the fundamental biology of RNA editing. To achieve
this breakthrough, I will harness a set of next-generation, multi-functional ribonucleoprotein devices, which can
detect the presence of specific RNAs in somatic cells and trigger the expression of effector genes for cell
visualization, monitoring, and manipulation. This method builds upon the universal RNA sensing and editing
system within all metazoan cells, centered around the editing enzyme adenosine deaminase acting on RNA
(ADAR). I term this method CellREADR (Cell access through RNA sensing by Endogenous ADAR). As
CellREADR leverages endogenous cellular machinery and is built with a single modular RNA molecule that
functions through Watson-Crick base pairing, it is highly specific, inherently programmable, fast, affordable, easy
to use, and widely applicable. I propose to build and optimize CellREADR devices in cell-culture systems and
validate the method in a highly complex organ - the brain - by targeting and manipulating a large set of neuronal
cell types in the mouse cerebral cortex. We will extend CellREADR across species by targeting cell types in ex
vivo human brain specimens, and in the macaque and avian brain. Further, we will design intersectional
strategies for targeting increasingly specific cell types, and combinatorial strategies for simultaneous and
differential manipulation of multiple cell types in a tissue. By linking cell-type RNA sensors to a variety of effector
genes that alter cell functions, ranging from ablation to subtle physiological modulation, we aim to edit cell
composition and function for next-generation tissue engineering. This technology will result in large arrays of
CellREADR libraries for targeting all major cell types across diverse species, akin to CRISPR-based gene editing
of diverse genomes. Thus, CellREADR will have a broad impact in basic biology, medicine, and biotechnology.

Public health relevance
Narrative I will develop a paradigm-shifting molecular genetic technology for identifying and manipulating cell types across organ tissues and animal species that is specific, easy, affordable, programmable, and general. This new technology has the potential to transform the scale and rate of discovery across biomedical fields, with clinical and industrial applications and sweeping impacts on human health.